REGISTRATION, STORAGE AND DISTRIBUTION OF CHEMICALS AND DRUGS FOR PRE-CLINICAL DISCOVERY, EVALUATION AND DEVELOPMENT

The purpose of this contract is to operate and maintain the National Cancer Institute's Chemotherapeutic Agents
Repository (NCI-CAR). The principal goals of this contract are 1) to support compound acquisition activities related
to the DTP anticancer pre-clinical drug evaluation program which seeks to identify new small molecule therapeutic
agents and 2) distribution of chemicals to intramural and extramural investigators for research purposes. The primary tasks of the contract are the receipt, registration, storage, analysis, arraying and distribution of small molecules and purified natural products that will be evaluated in DTP anti-cancer screens, and also distributed to extramural researchers.